Antigen recognition and activation of HIV-specific B cell antigen receptors

Abstract
B cell antigen receptor (BCR)-antigen interactions that govern the activation of B cells with a pre-vaccinated B-
cell repertoire are not clearly defined for HIV-1 broadly neutralizing antibody (bnAb) lineages. Our recent studies
show that B cell activation is dependent on antigen-binding association rate and not on the overall affinity (KD
value), indicating that antigen sensing has a kinetic component. In this renewal application we will expand our
studies to define the biophysical properties of antigen binding and cell surface interactions that lead to activation
of B cells expressing germline precursor or early lineage intermediate BCRs of different HIV-1 bnAb specificities
(CD4-binding site, V3-glycan). We will build upon our hypothesis that the exposure of the BCR to antigens that
bind with enhanced association kinetics leads to re-organization and localization of receptors with co-stimulatory
molecules on the B cell membrane, and together these parameters contribute to B cell activation and selection
of functional mutations that lead to the development of neutralization breadth. In Aim 1, we will use Ramos B
cell lines and purified BCR-complexes to perform biophysical interactions and structural analyses to define the
properties of BCR-antigen interactions that govern signaling and activation of bnAb precursors and selection of
functional mutations following immunizations in relevant knock-in mouse models. In Aim 2, we will define the
role of the CH1 domain in class-specific antigen sensing, and the role of the immunoreceptor coupling and
organization motifs (ICOM) interactome in the regulation and activation of HIV-specific BCRs on naïve and
memory-type B cells. In Aim 3, we will define priming and boosting immunogen activation ranges for bnAb
lineages to multiple Envelope targets and develop lineage-specific prime/boost combinations for testing in
physiologically relevant mouse models. The overall objective of this grant is to bridge quantitative measurements
of antigen-activated biophysical/biochemical events and B cell surface organization/interactions to optimal B cell
priming and boosting in relevant ex-vivo and in-vivo B cell activation models, and to use this information for
facilitating design and selection of immunogens for HIV-1 vaccine development.

Public health relevance
Project Narrative We will study how HIV-1 viral proteins are sensed by B cells expressing B cell antigen receptors (BCRs) of HIV- 1 broadly neutralizing antibodies and initiate signaling events for their activation. Using high-resolution assays and B cells from animal models expressing BCRs of HIV unmutated precursors, we will define the key properties of BCR-antigen interactions and B cell membrane events that promote co-stimulation and optimal B cell activation and lead to the development of anti-HIV protective antibodies. Our proposed work will guide and facilitate the development of anti-viral vaccines.